Rational Design of Magnetic Nanoparticles for Cochlear Drug Delivery

Abstract
I am a neurotologist and assistant professor in the department of Otolaryngology-Head and Neck Surgery at
the Johns Hopkins University School of Medicine. I am applying for a K08 mentored surgeon-scientist career
development award (CDA) to obtain further training related to chemical engineering-based approaches to
improving drug delivery in the ear for treatment of hearing loss. Specifically, I am interested in developing
magnetic nanoparticles as a novel drug delivery platform in the treatment of hearing loss. My long-term career
goals are to lead the translational development of novel drug delivery technologies that can enable the safe
and effective delivery of emerging pharmaceutics into the inner ear.
Despite rapid emergence of promising therapeutics such as protein-based neuronal growth factors and gene
therapies for various forms of sensorineural hearing loss, their clinical translation is limited by the lack of a
delivery vehicle that can be administered in a minimally-invasive and redoseable fashion in the clinic. Magnetic
nanoparticles have unique chemical and physical properties that may be well suited as a cochlear delivery
vehicle for macromolecular pharmaceutics. Their polymeric coating has payload capacity for proteins and
DNA, while their superparamagnetic iron oxide nanocores can move in a magnetic field gradient, allowing for
magnetically-assisted delivery across the round window membrane and into perilymph. However, rational
design of magnetic nanoparticles for cochlear drug delivery requires an understanding of how nanoparticle
properties relate to transport and pharmacokinetic behavior in the cochlea.
This CDA proposes leveraging my previous experience in translational engineering research of the inner ear to
elucidate how chemical and physical properties of custom-synthesized magnetic nanoparticles affect their
consequent transport properties as cochlear drug delivery vehicles in vitro and in vivo. Specific training goals
include: 1) training in nanoparticle science and drug delivery, 2) training in the guinea pig pharmacokinetic
model, and 3) training in immunohistologic and histologic assays of the temporal bone, 4) training in ethical
conduct of research, and 5) development of skills, techniques, and preliminary data that will lead to submission
of a successful R01 application.
The research plan investigates the hypothesis that nanoparticle size is an important mediator of magnetic
nanoparticle transport in the cochlea and performance as a drug delivery vehicle. Using a guinea pig model
validated for the study of perilymph pharmacokinetics of applied drugs, the specific aims of the proposal are to
understand the impact of nanoparticle size on 1) transport across round window membrane explants in vitro, 2)
perilymph concentration profiles and biodistribution in cochlear tissues in vivo, and 3) ability to deliver brain-
derived neurotrophic factor into cochlear perilymph in vivo.

Public health relevance
Project Narrative The research proposed here will investigate magnetic nanoparticles as novel drug delivery vehicles for the treatment of hearing loss using a preclinical animal model. Our goal is to understand how the physical and chemical properties of magnetic nanoparticles impact their performance as drug delivery vehicles in the ear.